The physical and molecular mechanisms of intestinal villus morphogenesis and repair

ABSTRACT
Villi are finger-like projection that line the lumen of the small intestine. Villi play a critical role in nutrient uptake
by increasing the intestinal absorptive surface area by several orders of magnitude. Loss of this absorptive
surface through villus atrophy causes major digestive complications and nutrient malabsorption. Abnormalities
in villi are found in many gastrointestinal maladies, such as inflammatory bowel and celiac diseases, and are
also side effects of radiation, chemotherapy, and infection. Degenerated villi can sometimes fully reform, yet in
other situations regeneration is impaired, resulting in persistent villus atrophy and patient suffering.
Villi emerge during development from an initially flat intestinal surface. The mechanisms underlying villus
formation and repair remain poorly described, and an understanding of these processes is essential to develop
new therapies. The long term goal of this proposal is to build an understanding of the molecules and forces that
sculpt the villus during development and regeneration so as to improve strategies for growing and regenerating
the intestine for human patients. Recent data from our labs suggest that the mesenchyme plays a central role in
sculpting the architecture of the villus. Specifically, our preliminary data implicate a specialized population of self-
organizing sub-epithelial mesenchymal cells that condense immediately below the forming villus as the source
of the physical forces necessary to pattern and fold the overlying epithelium into villi. We investigated the
molecular mechanisms leading to condensation of these cells using single cell RNAseq and found they also
express a unique transcriptional program. This program has an unusual overlap with genes regulating Ca2+
mediated contractility in smooth muscle cells but without expressing smooth muscle actin. We provide evidence
that inhibition of key proteins in this program results in a loss of mesenchymal condensation and villus
evagination. Guided by these preliminary data, we propose to test two hypotheses related to the complementary
physical and molecular aspects of villus formation. We combine quantitative measurements and computational
modeling to test the hypothesis that the formation of villus condensates occurs analogously to phase separation
phenomena studied extensively by physicists and material scientists, and that condensates exert physical forces
on the overlying epithelium initiating its folding. We then test the hypothesis that Endothelin released from the
epithelium triggers increased calcium signaling in the subepithelial mesenchyme, which are synchronized
through gap junctions to drive cell contractility leading to phase separation and condensation.
This project has major implications for our fundamental understanding of the developmental of the gut and for
tissue engineering of intestinal tissue, as we do not know how mammalian intestinal villi are built. Thus, these
findings will be impactful because they provide a new mechanistic blueprint for this process that incorporates
both signals and forces. These findings will also lay the groundwork for future studies of regeneration: we find
that in adults, the sub-epithelial mesenchyme retains expression of many of these molecular features. Further,
these features are upregulated following injury.

Public health relevance
PROJECT NARRATIVE Intestinal villi are finger-like projections that increase the intestinal absorptive surface area nearly 100-fold. Abnormalities in villi are found in many gastrointestinal maladies, such as inflammatory bowel and celiac diseases, and are also side effects of damage induced by radiation, chemotherapy, and infection. The regenerative process of villi is often impaired, and persistent villus atrophy can cause significant clinical challenges. In this application, we will determine forces and molecules that act in the mammalian embryo to shape the villi, which will aid in the design of new strategies to promote villus regeneration in vivo and to build replacement tissue ex vivo.